Enabling long timestep molecular dynamics on parallel CPU and GPU environments

DESCRIPTION (provided by applicant): Support is requested for the development and implementation of novel computational methods for simulating the long timestep dynamics of proteins and the application of these methods to study the relation between motions and biological functions in flexible proteins. This will satisfy an urgent need for high-fidelity methos that reach biologically relevant timescales of microseconds to milliseconds of simulation, rather than the nanoseconds to microseconds simulations that are commonly available. While conformational change has itself been studied computationally for many years, our proposed work differs from other approaches in (1) the high-performance implementation of novel methods for long timestep dynamics and enhanced sampling at all-atom resolution and (2) the application of these detailed methods to address questions of flexibility and function in biomolecules of biomedical relevance. Since a quantitative comparison to experiment is critical for both the testing and greater impact of our computational methods, experimental collaborations are proposed. These are documented by letters of support. This project will have a widespread impact on NIH-funded researchers because the target parallel software packages already have a large user base and have an open code source. Longer MD simulations will allow previously impossible studies to be carried out in the fields of protein folding, protein engineering, enzyme design, drug design to flexible targets, and interactions among protein and nucleic acid complexes. PUBLIC HEALTH RELEVANCE: This proposal seeks support for numerical methods that allow the simulation of protein conformational changes in the millisecond timescale, which already allow hundred-fold speedups over traditional molecular dynamics for proteins. With proposed improvements to the methods, implementation in GPUs and parallel CPUs and public dissemination in widely used software, more complex and powerful studies of protein folding, allostery, and protein engineering will be possible. These developments will be guided by the combined experimental - simulation study of the engineering of mutants of a protein of importance in regulating the cell cycle that is a potential target for Alzheimer's disease and cancer.

Public health relevance
This proposal seeks support for numerical methods that allow the simulation of protein conformational changes in the millisecond timescale, which already allow hundred-fold speedups over traditional molecular dynamics for proteins. With proposed improvements to the methods, implementation in GPUs and parallel CPUs and public dissemination in widely used software, more complex and powerful studies of protein folding, allostery, and protein engineering will be possible. These developments will be guided by the combined experimental - simulation study of the engineering of mutants of a protein of importance in regulating the cell cycle that is a potential target for Alzheimer's disease and cancer.